Infectious Diseases Training program in Bolivia: South-South Training with Peru

PROJECT SUMMARY
In this application, we propose to continue our training program to achieve a critical mass of
researchers in Bolivia, where we are building local expertise. We will employ a successful progressive
stepwise method of selecting and training young investigators in Bolivia. This stepwise training method permits
screening of candidates at multiple levels and ensures that we invest in the most highly qualified and motivated
individuals. The proximity of Bolivia to Peru provides us with a unique opportunity to leverage the human
capacity and infrastructure that we have built in Peru over the last 25 years, using a South-South training
approach to more cost-effectively begin to build a scientific research community in Bolivia.1 Several infectious
diseases affect public health in Bolivia, and we plan to focus our training on a few of the most important to the
country: Chagas disease, cysticercosis, tuberculosis (TB), pneumonia, and HIV neurological co-infections.
Over the past 25 years, we have developed a training network of developing and developed country institutions
that is remarkable for its breadth, depth, and sustainability. This program began with a focus on Peru and has
trained more than 95 Peruvian graduate and post-graduate students and 500 students of other nationalities.
The collaborative network of individuals and institutions tied to this grant has produced more than 500 original
research articles in peer-reviewed journals. This network and infrastructure developed in our original program
in Peru was used as the model to train researchers in Bolivia. We will continue the South-South training
approach used in the first five years of the program to train researchers in Bolivia.
We have the following steps in our program that will be completed under this D43 grant:
Step 1. We will train 20+ students each year in infectious disease and research methods seminars in Bolivia,
for a total of 100+ students during the five-year grant.
Step 2. We will train four students per year in laboratory rotations at the UPCH, for a total of 20 trainees during
the 5-year grant.
Step 3. We will train six students per year in laboratory rotations in Bolivia, for a total of 30 trainees during the
5-year grant.
Step 4. We will train two Bolivian students per year in a master’s degree program at UPCH, for a total of ten
trainees during the five-year grant.
Step 5. We will support 10 Bolivian students to attend the Tropical Medicine and Public Health Summer
Institute at JHSPH during the five-year grant.
Step 6. Four Ph.D. candidates at USA or U.K during the five-year grant.

Public health relevance
PROJECT NARRATIVE For more than 25 years, the collaboration among the Johns Hopkins University Bloomberg School of Public Health, the Universidad Peruana Cayetano Heredia in Peru, and A.B. PRISMA, a Peruvian non-governmental organization, has provided a rich environment for research and training. This collaboration is focused on developing local infrastructure and scientific talent in the area of infectious diseases, and we propose to continue to train and develop research and diagnostic capacity in Bolivia using our South-South training approach.